Administrative Core

PROJECT SUMMARY ─ ADMINISTRATIVE CORE
Boise State University is an emerging research university with an expanding base of investigators working on
solutions to national and global healthcare problems. The objective for the proposed COBRE in Convergent
Engineering and Biomolecular Science (CEBS) is to enhance collaborative and convergent research among
Boise State University’s growing cohort of engineers and biomolecular scientists pursuing biomedical research
in devices, sensors, and systems. The administrative core (AC) will oversee the career development
opportunities for research project leaders and CEBS associated investigators. The AC will organize (1) a
professional development committee, (2) an internal advisory committee (IAC), and (3) an external advisory
committee (EAC). The AC will schedule regular committee meetings, including an annual review with the EAC
to review program progress and elicit feedback. The AC will support professional development through
conferences, grant writing workshops, convergent Science of Team Science training, seminar series, and
travel and networking opportunities. The AC will provide fiscal support through grants accounting, hiring, travel,
purchasing, and annual progress reporting. The AC will oversee the creation and management of a
consolidated Fabrication, Characterization, and Testing Core from existing engineering service facilities. The
AC will implement a Pilot Project grant program for new and established investigators who propose research in
the CEBS thematic area. An undergraduate summer internship will also be established and managed by the
administrative core. In managing these activities, it is the goal of the Administrative Core to sponsor growth
and training for multidisciplinary teams working to contribute solutions to the growing global need for medical
devices and sensors to address human healthcare problems.